Salivary gland response to Desert hedgehog signaling as an antidote to damage from therapeutic radiation

PROJECT SUMMARY/ABSTRACT
Salivation is a critical physiological activity that aids digestion, maintains oral health, and supports functions such
as speech, swallowing and taste sensation. Salivary gland dysfunction results from ageing, diseases such as
Sjögren syndrome and from radiotherapy for head and neck cancers. Therapeutic irradiation causes permanent
damage to salivary glands, highlighting their poor regenerative ability. One potential obstacle to recovery of
salivation may be that damage, particularly during radiation therapy, is inflicted not only on saliva-generating
epithelial cells but also on supporting mesenchymal cells. Indeed, preservation or restoration of mesenchymal
cell function may constitute an ideal therapeutic target, as an optimized mesenchymal microenvironment may
augment the function and regenerative capacity of residual salivary gland epithelial cells and their progenitors.
A knowledge of how mesenchymal cells function during homeostasis and contribute to regeneration after injury
thus may provide a new approach to activate mechanisms that protect salivary glands and enhance their repair.
In many organs the mesenchymal expression of signals that provide regenerative feedback to the epithelium
during homeostasis and injury repair is induced by expression of a Hedgehog (Hh) protein signal from the
epithelium. Using mouse genetic models, cell lineage tracing, and single-cell transcriptomics, we have
discovered that Desert hedgehog (DHH), the least studied of the three mammalian Hh family members, drives
an epithelial-mesenchymal feedback (EMF) circuit in the major adult salivary glands, and that activity of this
circuit is crucial for salivary gland maintenance and for regeneration after radiation injury. Importantly, although
DHH expression in cells of the salivary gland epithelium is essential for regeneration, our findings also highlight
a vital role for mesenchymal response to this signal for execution of the regenerative program.
Here we propose to elucidate the role of Hh signaling in salivary gland homeostasis and regeneration by
characterizing at a single cell level the transcriptomic and epigenetic consequences of EMF circuit activity, and
to assess the conservation of DHH-driven EMF circuitry in human salivary glands. With the goal of manipulating
Hh pathway activity for protection from or enhancement of tissue repair after radiation injury, we have developed
a conformation-specific nanobody against the Hh receptor Patched1 that activates Hh pathway response. This
nanobody can be targeted to specific cell and tissue types, thus mitigating potential adverse effects arising from
systemic Hh pathway activation. With this agent, we will test the possibility that precise, tissue-targeted activation
of the Hh pathway can effectively enhance endogenous reparative mechanisms for salivary gland protection
from and restoration after injury from irradiation like that administered in head and neck cancer therapy.

Public health relevance
PROJECT NARRATIVE The process of salivation, which aids digestion and performs an indispensable role in lubricating and protecting the oral cavity, is disrupted in several conditions including radiation therapy for head-and-neck cancer. We have discovered a two-way signaling circuit between salivary gland surface cells and underlying support cells, and have found that activity of this circuit is essential for salivary gland maintenance and function. In our proposed research we will test the possibility that precise activation of this circuit may protect against and stimulate recovery from radiation-induced salivary gland damage.